Role of the Type III TGFbeta Receptor in Valvulogenesis

[unreadable] DESCRIPTION (provided by applicant): Peptide growth factors, such as the Transforming Growth Factor beta (TGF-beta) family, play central roles in morphogenesis and organogenesis. Our long-range goals are to determine how growth factors, like Transforming Growth Factor beta (TGF-beta), participate in organogenesis. Here the goal is to elucidate the role of the TBRIII in valvulogenesis. We will test the hypothesis that TBRIII mediates valvulogenesis in the mouse using both a complete and a conditional deletion of tbriii. Our laboratory has generated a floxed and null allele of tbriii and we will use Tie2-Cre to ablate tbriii in endothelial cells. We will use a combination of histological, marker analysis, and experimental embryology to fully characterize the role of TBRIII in valvulogenesis. These studies will contribute to our fundamental knowledge of the role of growth factors, such as TGF-beta, in mediating valvulogenesis. These studies are of clinical significance since a portion of congenital heart disease is due to abnormalities in valve development. [unreadable] [unreadable] [unreadable]